Project 4: Combined targeting of DNA repair and macrophage-mediated immunosuppression in BRCA1/2-associated breast cancer

PROJECT SUMMARY/ABSTRACT
Inhibitors of poly (ADP-Ribose) polymerase (PARP) are now part of the standard armamentarium for patients
with BRCA-associated breast cancer. Mechanistically, these agents not only induce synthetic lethality in
homologous recombination (HR) repair-deficient tumor cells but also induce cGAS-STING-mediated immune
responses that result in CD8+ T-cell infiltration and activation. Although these immunomodulatory effects are
critical for maximal efficacy of PARP inhibition, to date, the addition of PD-1/L1 blockade has not improved PARP
inhibitor efficacy in preclinical models or in clinical trials. Our recent preclinical work has demonstrated that
PARP inhibition also results in infiltration of CSF-1R+ tumor-associated macrophages (TAMs) that carry a highly
immunosuppressive phenotype. CSF-1R blockade depletes these TAMs and significantly augments PARP
inhibitor efficacy in BRCA-deficient models in a CD8+ T-cell-dependent manner. In the first Specific Aim, these
preclinical findings will be validated in biopsies procured from patients with BRCA-associated breast cancer who
have received PARP inhibitor-based treatment on clinical trials. In the TALAVE trial, patients received one month
of talazoparib alone, followed by cycles of talazoparib/avelumab, with biopsies obtained pre-treatment, after
talazoparib alone and after the combination. A neoadjuvant trial combining niraparib and dostarlimab will also be
leveraged, in which pre-treatment, on-treatment and surgical specimens will be available for analysis. RNA
sequencing and single-cell, multiplex cyclic immunofluorescence (CyCIF) will be used to deeply characterize
both the T-cell and TAM components of the tumor microenvironment (TME) in response to PARP inhibition. TAM
diversity before and on-treatment will be explored based on transcriptionally defined unique subsets. The
topology and spatial relationships of TAMs with T-cells will also be explored. In Aim 2, a Phase 1 clinical trial
combining the anti-CSF-1R antibody axatilimab and olaparib will be conducted in patients with PARP inhibitor-
naïve or sensitive metastatic BRCA-associated breast cancer. Tumor biopsies will be obtained pre-treatment,
after a 2-week lead-in of olaparib alone, and after combination treatment to perform proof-of-mechanism
pharmacodynamics to document depletion of CD163+CSF-1R+ immunosuppressive TAMs. Finally, in Aim 3,
combined CSF-1R blockade and PARP inhibition will be studied in preclinical immunocompetent models of
BRCA1-deficient breast cancer with acquired PARP inhibitor resistance. Because the efficacy of this strategy is
dependent on activation of CD8+ T-cells, and based on a greater degree of TAM infiltration and immune
checkpoint protein expression in PARP inhibitor-resistant tumors, combined anti-CSF-1R and olaparib will also
be studied with immune checkpoint blockade, including anti-PD-1 and anti-TIM-3, the latter shown to activate
dendritic cells in a cGAS/STING-dependent manner. Taken together, these studies will define the T-cell and TAM
components of the TME in response to PARP inhibition in patient samples and develop the strategy of combined
CSF-1R blockade and PARP inhibition in PARP inhibitor-sensitive and resistant tumors.

Public health relevance
PROJECT NARRATIVE Although PARP inhibitors exert synthetic lethal effects and activate cytotoxic T-cells in BRCA-deficient breast cancer models, their efficacy is limited by the concomitant infiltration of immunosuppressive macrophages. These findings will be validated in biopsies from patients receiving PARP inhibitors on clinical trials, and CSF- 1R blockade will be combined with PARP inhibition in a clinical trial to deplete pro-tumor macrophages and maximize cytotoxic T-cell activation. This strategy will also be explored in models with acquired PARP inhibitor resistance, with the goal of optimizing combined inhibition of DNA repair and immunomodulation to improve outcomes for patients with BRCA-associated breast cancer.